Impact of hypertension and high-fat diet on mechanisms by which estradiol affects cortical synaptic plasticity.

Project 2 Summary
The menopausal transition is responsible for many of the cognitive impairments reported by women at midlife.
In addition to the detrimental effects of the natural loss of endogenous hormones on cognition, and as a probable
consequence, the prevalence of Alzheimer’s disease and other related dementias is higher in women than men,
with double the lifetime risk of Alzheimer’s disease at age 45. Hormone therapy is the most effective treatment
for the vasomotor and sleep disruptions that accompany menopause, but timing of the intervention may have a
crucial impact on overall outcome, particularly on the preservation of cognitive capabilities. Whereas late
hormone therapy interventions have no benefit, or may even be harmful, early interventions seem to bestow
protection against cognitive decline, regardless of the presence of Alzheimer’s disease pathology. In addition,
cardiovascular and metabolic complications are directly associated with sharper cognitive decline, which
together with the loss of endogenous estrogens, may further increase the risk of developing Alzheimer’s disease
and vascular dementia. While it has been described that hypertension and metabolic disease impair
neurovascular coupling—the fine-tuned mechanism that matches local blood supply with neuronal activity—it is
unknown if disrupted neurovascular coupling is ultimately responsible for the loss of cognitive protection by
estrogen. Given that the mechanisms governing neurovascular coupling are tightly regulated by endothelial nitric
oxide synthase, we believe that cardiometabolic comorbidities negatively impact the availability of nitric oxide to
the extent that it abolishes the estrogen-induced neuroprotection. Therefore, our working hypothesis is that
hypertension and metabolic disease prior to menopause impede the beneficial effects of hormone therapy in
preventing aging-related cognitive decline by blunting neurovascular coupling. This leads to impaired local
network activity, and therefore, to impaired synaptic plasticity required for the formation and stabilization of
synapses needed to create functional cortical circuits and therefore for cognition. We will also test the hypothesis
that increasing endothelial nitric oxide synthase activity and nitric oxide bioavailability will eliminate the deficits
in neurovascular coupling. This study will determine that the preexistence of hypertension and obesity-induced
metabolic disease prior to ovariectomy nullifies the positive effects of midlife estradiol treatment on synaptic
plasticity and synaptic stabilization, impairing the ability of cortical circuits to store and manage information, and
will identify alterations in the cortical microcircuitry responsible for the deficient experience-dependent synaptic
plasticity. The study will also examine the role of mitochondria in disrupted neuronal activity and characterize the
molecular mechanisms mediating the impaired neurovascular coupling that is associated with the loss of
estrogen’s neuroprotective effects. Focusing on a cortical circuit that we can comprehensively study and
manipulate, this study will create foundational knowledge for the design and improvement of personalized or
precision interventions aimed to prevent or treat cognitive disturbances in postmenopausal women at risk for
Alzheimer’s disease and vascular dementia.